SMART Core

Abstract
The Sequencing, Molecular and Related Technologies (SMART), and Data Science
Cores are a centralized resource that provides genomic research services, access to
genomic and nucleic acid analysis instrumentation, and support for the analysis of
genomic data. Working together these two cores will offer their services in support of the
proposed WV-INBRE network and its investigators. In collaboration with the Data Science
Core, the SMART Core will provide genomics services that are needed by lead and
undergraduate investigators to support the Developmental Research Project Program.
These services include (1) high throughput next-generation sequencing (NGS) to support
whole genome, whole exome, RNA-Seq, microbiome and global chromatin studies, (2)
experimental design and bioinformatic guidance and analysis for genomic projects, (3)
access to DNA/RNA sequence analysis software, (4) RNA/DNA quality assessment, and
(5) access to shared instrumentation used in basic genomic analysis. To keep pace with
new technologies, we will offer single-cell and spatial transcriptomics as new NGS
services that will be available to INBRE investigators in the next phase of the INBRE
program. These services are most efficiently executed in a core facility with expertise in
genomic analysis. The SMART and Data Science Cores will work together to also provide
training in genomic methods which will include workshops on existing and emerging next-
generation sequencing methods as well as one on consultation to ensure that WV-INBRE
investigators can take advantage of NGS technologies and design robust experiments.
Our business model includes a full-service plan that integrates SMART and Data Science
Core expertise for the provision of NGS and associated NGS bioinformatic analysis. We
anticipate that our model and guidance from our experienced staff will allow WV-INBRE
investigators to successfully adopt genomic approaches in their research and generate
useful data. Our primary aim is to enable the genomic and bioinformatic research
goals of investigators supported by the INBRE application and to assist biomedical
science investigators in their genomic research needs. Their findings will identify
genes and changes in chromatin structure and pathways that provide a deeper
mechanistic understanding of the molecular basis of chronic diseases that are common
in West Virginia, which will foster new therapies to treat these diseases.

Public health relevance
The Sequencing, Molecular and Related Technologies (SMART) Core is a centralized resource that provides genomic research services, access to genomic and nucleic acid analysis instrumentation, and support for the analysis of genomic data. These technologies and service will help investigators identify genes associated with a particular disease and/or the proper function of normal tissue and lead to the discovery of novel therapeutics.